Novel ISH Approaches to Quantify Replication Competent Reservoirs

PROJECT SUMMARY
The major obstacle to an 'HIV cure' is the persistence of viral reservoirs (VR) harboring replication competent
viral genomes that have the capacity to produce infectious virus. These VR persist for long periods of time, and
even after years of suppressive ART, the systemic spread of virus resumes within a few weeks upon cessation
of ART in all but exceptional cases. Effective cure strategies will need to dramatically reduce or eliminate VR
through safe and scalable approaches. It is currently thought that the major VR are long-lived latently infected
resting memory CD4+ T cells, which remain quiescent until they are stimulated by external cues to produce virus.
In addition to the truly latent VR, emerging data shows that in individuals on suppressive ART a subset of VR
transcribe viral RNA (vRNA+) at variable levels (termed ‘active VR’). In some individuals, this might lead to
residual levels of HIV replication, particularly in tissue microenvironments where drug concentrations are
suboptimal. Even without full viral replication, this residual expression of virus may have adverse consequences
and contribute to chronic immune activation/inflammation and non-AIDS defining clinical events. Eradicating HIV
will require targeting both the ‘latent’ and ‘active’ VR, however, our current understanding of HIV reservoirs
comes mostly from studies performed in peripheral blood, but the blood contains only a small fraction of VR
during ART. We reason that to maximize efficacy of ‘HIV cure’ strategies, we need to first better characterize
both the tissue compartments and the cellular subsets from which infection might rebound in HIV-infected
individuals after ART is interrupted. Thus, the overarching goals of this research proposal in response to FOA
PA-17-305 "Imaging the Persistent HIV Reservoir" are to validate and apply novel microscopic and flow
cytometric RNA and DNA in situ hybridization (ISH) platforms that allow multiparametric single-cell
characterization of VR with various levels of residual transcription and/or translation. We will use these
approaches in HIV-infected samples and a NHP model of SIV infection, which allows detailed studies of diverse
tissues. In Aim 1, we will optimize our unique ISH platforms to identify and characterize ‘latent’ and ‘active’ VR
with putatively intact viral genomes and distinguish VR with different levels of transcriptional and translational
activities. We will define relationships between classical VR (e.g., PCR) and ISH-based measurements and
determine key differences between VR measures in the blood compared to different tissue environments, as
well as a comprehensive analysis of the “immune neighborhoods” and “inflammatory landscapes" in which VR
reside. In Aim 2, we will perform an interventional study using infection with SIVmac239M barcoded virus and
determine the relationship between novel ISH measures of VR in blood and tissues with time to viral rebound in
SIV-infected RMs after ART cessation. We hypothesize that these ISH measures are more likely to predict time
to viral rebound and the number of rebounding viruses upon ART interruption than conventional assays and
believe that these powerful new approaches will be important in monitoring VR in future clinical trials.

Public health relevance
PROJECT NARRATIVE Although lifelong suppression of HIV replication with antiretroviral therapy (ART) seems possible, side effects, need for strict adherence, resistance, stigma and cost all contribute to the necessity of finding an ‘HIV cure’. As a model for HIV infection, and to better understand viral reservoirs in different organs and cell types, we propose to apply novel imaging techniques called microscopic and flow cytometric RNA and DNA in situ hybridization (ISH), to monkeys infected with the simian immunodeficiency virus (SIV), allowing an in-depth single-cell characterization of viral reservoirs with various levels of residual activity in terms of the expression of viral products. We will conduct these studies: i) to better understand the relationships between measures of viral persistence in blood compared to tissue compartments and ii) to better predict time to viral rebound upon ART cessation.